Genomic Analysis of Epithelial Growth and Repair Mechanisms in Aspirin Exacerbated Respiratory Disease

Abstract/Project summary Aspirin Exacerbated Respiratory Disease (AERD) is a relatively homogeneous disease characterized by adult- onset severe asthma, development of non-cancerous growths in the nasal canal (i.e. nasal polyps) and aspirin allergy. The cause of AERD is unknown, although likely results from environmental insults in combination with genetic susceptibility. AERD disease homogeneity increases the possibility of discovering narrowly-defined genetic contributors, and makes it an ideal population to study the genetic and epigenetic changes that cause asthma. We recently discovered that gene expression of epithelial growth and repair (EGR) genes are substantially decreased in bronchial airway epithelial cells of severe asthmatics compared to less severe asthmatics and healthy controls. This new finding indicates that epithelial integrity and related processes may be of primary importance to the development of severe asthma, and potentially the severe asthma subtype, AERD. This finding was later supported in a subsequent lab model, which showed that blocking a central epithelial repair and differentiation gene, human epidermal growth factor receptor 2 (ERBB2), decreased healing time of bronchial epithelial cells after injury. Thus, the objective of the proposed study is to determine whether EGR gene are also down-regulated in AERD, a homogeneous severe asthma subtype. As an extension, we will also determine whether genetic mutations and/or epigenetic changes relate to and potentially explain this down-regulation of EGR genes. Specifically, we plan to obtain gene expression of freshly brushed nasal airway epithelial cells of 75 AERD patients and 35 healthy controls, noting that nasal epithelial gene expression has recently been shown to mirror lung epithelial changes in asthmatic airways. Swabbing the nasal canal for epithelial cells allows to evaluate airway epithelial cell gene expression non- invasively. Our experimental design contrasts AERD gene expression profiles against healthy controls, and determines whether EGR genes are depressed in AERD relative to health controls. As a corollary, we look to discover an AERD-specific gene expression profile which may one-day aid in diagnosis and expand current knowledge of disease mechanisms. As an extension, we will correlate gene expression changes, specifically any finding of down-regulated EGR genes, with methylation changes (i.e. epigenetic changes) and genetic mutations. This K23 funding will provide protected research time to become an independent physician researcher. My prior and current training in statistics, bioinformatics, and gene expression analysis is complemented by specialized clinical training in the care of severe asthma patients. Thus, I have a unique clinical and computational expertise to perform the data analysis, and interpret and integrate genomic findings in a clinical and biological context. I have chosen mentors that are leading experts in the fields of immunology, severe asthma, AERD and genomics. I am currently in the ideal environment to execute the proposed investigation.

Public health relevance
Project Narrative Aspirin Exacerbated Respiratory Disease (AERD) is a subtype of severe asthma with coexistent inflammation of the nasal cavity, the development of non-cancerous growths (e.g. nasal polyps), and an allergy to aspirin. The etiology of AERD (similar to asthma itself) is unknown, although it is thought to result from a combination of genetic susceptibility and environmental insults. The proposed study is aimed at determining the gene expression changes, genetic mutations and/or epigenetic changes associated with the development of AERD by performing gene expression, epigenetic, and genetic mutation profiling on freshly brushed nasal airway epithelial cells of 75 AERD patients in comparison to 35 healthy controls.